BACTERIAL RESISTANCE TO AMINOGLYCOSIDE ANTIBIOTICS

We are attempting to identify the active site in aminoglycoside 3'-phosphate transferase type IIa. This protein is a member of the family of bacterial aminoglycoside-modifying enzymes that enable bacteria to resist this type of antibiotics.